METHOTREXATE IN SEVERE JUVENILE RHEUMATOID ARTHRITIS

The goal of the project is to establish the safety and efficacy of low dose oral methotrexate (MTX) in the treatment of severe recalcitrant juvenile rheumatoid arthritis (JRA).